I. Institutional Career Development Core

ABSTRACT
The goal of the ITM CTSA KL2 Scholar program is to produce accomplished researchers capable of utilizing
the tools of clinical and translational research to improve the understanding or treatment of human disease.
Research topics can relate to any aspect of clinical and/or translational research and to any patient population
or disease group. Any suitable research approach can be employed. However, relevance to the understanding
or treatment of human disease must be demonstrated. In ITM 3.0, we will particularly emphasize the impact of
health disparities during the training of our KL2 Scholars across the translational research spectrum, so that
they are able to consider issues related to different groups (such as race, ethnicity, SES, gender, age,
communication strategies for these different audiences, etc.) and sociome factors (social, environmental,
behavioral, and psychological), and account for these in complex intersectional designs and approaches.
Our program's track record demonstrates a high degree of success in supporting junior faculty to successful
academic research careers. Since inception of our KL2 program in 2008, we have had or currenUy have 30
Scholars in our program. Of these 30 Scholars, 13 (43%) have transitioned to R01 or comparable funding with
several still likely to make this transition in the near term. This demonstrates the ability of our program to
produce Scholars with high-impact, innovative research that aligns well with the emerging directions at NIH
and in the scientific community. While 20% of our Scholars to date self-identify as underrepresented
minorities, in ITM 3.0 we will further increase our effort to attract Scholars from underrepresented backgrounds.
We anticipate supporting ~2 years of multidisciplinary training for each selected junior faculty member, who will
devote >/=75% effort to investigation and training (>/=50% for surgeons). The program will include five KL2
Scholars at any time {drawn primarily from UChicago and Rush, but occasionally from other ITM affiliates), and
its impact will be extended greatly beyond this relatively small number through co-training and extensive
interactions with K Scholars in other career development programs at the lead ITM institutions (UChicago and
Rush University) and its affiliates as well as with inclusion of numerous individual K-award (or equivalent)
recipients and K-award aspirants at all ITM institutions.